Allosteric regulation of lysine degradation as a novel pathophysiological mechanism in glutaric aciduria type 1

In this project, the investigators propose to study the allosteric mechanisms that regulate lysine degradation and gain novel pathophysiological insights into the rare orphan disease glutaric aciduria type 1 (GA1). GA1 is an autosomal recessive inborn error of lysine, hydroxylysine and tryptophan degradation. Patients can present with brain atrophy and macrocephaly and may develop dystonia after acute encephalopathic crises that lead to striatal degeneration. The disorder is caused by a deficiency of glutaryl-CoA dehydrogenase (GCDH), which leads to the accumulation of neurotoxic glutaric acid and 3-hydroxyglutaric acid. GA1 is considered a treatable disorder and therefore included in newborn screening programs in many countries. However, current treatment consists of dietary intervention, carnitine supplementation, and emergency treatment which requires intense efforts from both caregiver, patient and clinical team. It must be meticulously maintained, but in 25% of patients neurological disease still develops. Thus, GA1 treatment needs further improvement, but development of new therapies is hampered by limited understanding of pathophysiological mechanisms. In human patients and the GA1 mouse model, symptomatic disease is accompanied by a striking increase in neurotoxic glutaric- and 3-hydroxyglutaric acid accumulation. The investigators hypothesize that the accumulation of toxic metabolites in GA1 due to the deficiency of GCDH is controlled by allosteric regulation of the lysine degradation pathway. In a high throughput screen, they have identified small molecule inhibitors and activators of the lysine-2-oxoglutarate reductase domain (LOR) of 2-aminoadipic semialdehyde synthase (AASS). This led to the discovery of a remarkable potential for allosteric regulation of this key enzyme in lysine degradation. Structural studies revealed two novel allosteric sites in LOR, one able to bind inhibitors, the other binding activators. Therefore the overall objective of this proposal is to understand the allosteric regulation of lysine degradation. In AIM 1, the structural and biochemical mechanisms of allosteric regulation of LOR/AASS will be studied using X-ray crystallography of LOR/AASS in complex with allosteric activators/inhibitors and enzymology. In AIM 2, the biological significance of allosteric regulation of LOR/AASS and its role in determining lysine degradation flux will be studied. The investigators will identify endogenous inhibitors and activators of LOR/AASS, and define the native protein interaction network of AASS. This knowledge will be used to define how this allosteric mechanism controls lysine degradation and contributes to metabolite accumulation in a GA1 cell line model. In AIM 3, neutral activators of LOR/AASS will be developed using a combination of medicinal chemistry and structure-based drug design. The ultimate goal of this project is to better understand the pathophysiology of GA1 and provide new treatment options.

Public health relevance
Modified B1 RPPR Section Glutaric aciduria type 1 (GA1; MIM 231670) is a neurometabolic disorder caused by a defect in lysine degradation. GA1 is one of the “core” conditions on the Recommended Uniform Screening Panel. After a confirmed positive newborn screen, patients are treated through dietary intervention, carnitine supplementation, and emergency intervention. This treatment paradigm requires intense efforts from caregiver, patient and medical professionals. It must be meticulously maintained, but in spite of these interventions, ~25% of patients will still develop irreversible neurological disease. The patient outcomes vary considerably and are strongly associated with quality of the treatment. Long-term complications are also becoming a more prominent concern. Thus GA1 treatment needs further improvement, however, new therapeutic development is hampered by limited understanding of pathophysiological mechanisms. In this R01 proposal, we will increase knowledge of GA1 pathophysiology by studying newly discovered allosteric regulation of 2-aminoadipic acid semialdehyde synthase (AASS), a key enzyme of lysine degradation. As a result, this knowledge will open potential new strategies to treat this rare and orphan disease. AASS catalyzes the initial and rate-limiting step in lysine degradation and is the main contributor to metabolite accumulation in GA1. With our previous R21 funding, we are developing pharmacological substrate reduction therapy. To that end, we have performed a >100,000 small molecule high-throughput screen (HTS) of the lysine-2-oxoglutarate reductase (LOR) domain of AASS leading to the identification of both novel allosteric inhibitors and activators. Specifically, two allosteric small molecule inhibitors (I2 and I4) are able to block AASS activity, and, relevant to this application, two allosteric small molecule activators (C1 and C2) are able to increase LOR activity. Further biochemical and structural studies revealed a remarkable potential for allosteric regulation of LOR/AASS. In humans and the GA1 mouse model, symptomatic GA1 disease is accompanied by a striking increase in neurotoxic glutaric- and 3-hydroxyglutaric acid accumulation. Based on these observations, we hypothesize that the accumulation of toxic metabolites in GA1 due to the deficiency of glutaryl-CoA dehydrogenase (GCDH) is exacerbated by allosteric activation of AASS. As such, this mechanism will be a major player in the pathophysiology of acute encephalopathic crises in GA1 and therefore, the prevention of allosteric activation of LOR/AASS may be a novel treatment modality for GA1. The overall objective of this proposal is to understand the mechanisms of the allosteric regulation of lysine degradation. To reach this objective, we have proposed the following specific aims: Aim 1: To learn the mechanisms of allosteric regulation of LOR/AASS using structural biology and enzymology. We will perform X-ray crystallography of LOR/AASS in complex with allosteric activators/inhibitors to characterize binding modes and compare these structures with structures of the apo-LOR enzyme to identify underlying conformational changes. We will use enzyme measurements to delineate the effect of allosteric regulation on the kinetics of the AASS enzyme. Aim 2: To define the biological significance of allosteric regulation of LOR/AASS and delineate its role in determining lysine degradation flux. We will identify endogenous activators and inhibitors of LOR/AASS through screening of an unbiased metabolite library and selected lysine derivatives. We will also identify proteins interacting with LOR/AASS through immunoprecipitation and proteomic analysis. We will modulate LOR/AASS activity through allosteric mechanisms in GA1 cell line models and determine its effects on lysine degradation flux and metabolite accumulation. Aim 3: To develop neutral activators targeting the allosteric site. We will perform medicinal chemistry structure activity relationship (SAR) studies of C1 and C2 to identify important pharmacophores responsible for enzyme activation and develop preliminary SAR. We will also use knowledge from binding modes identified through structural biology studies in Aim 1. We will then use the understanding of the mechanisms of action, binding modes and structural requirements for activity to develop C1 and C2 into neutral or inverse activators that bind to the allosteric site, but block activation or limit enzyme activity, respectively. We expect that the identification and study of allosteric regulation of LOR/AASS will not only increase our understanding of lysine catabolism and GA1 pathophysiology, it will also pave the way for the development of a new therapeutic approach for treatment of GA1 aimed at prevention of LOR/AASS activation. We anticipate that such a therapeutic could be a small molecule that binds to the allosteric site but prevents LOR/AASS activation. This approach has the advantage that it reduces the potential for hyperlysinemia, even though it is a biochemical abnormality of unknown clinical significance. The successful completion of these aims may also provide knowledge on allostery in general that can be applied to other metabolic diseases.